NEURONAL MECHANISMS OF COGNITION

The long-term objective of this project is to elucidate the cellular and circuit basis of processes in prefrontal cortex which are involved in working memory. This will be achieved by investigation of both: (a) the scope of working memory domains, and (B) the neuromodulation of participating local circuits using the method of single-cell recording in trained monkeys. Prior work at this Center, using oculomotor versions of the spatial delayed-response task, has shown that neurons in dorsolateral prefrontal cortex can hold visuospatial information "on- line"" for many seconds during the delay period of the task. We propose to extend our knowledge of working memory systems to the object and auditory domains of information processing as these are particularly relevant to schizophrenia. We will build on working progress to further characterize the neuronal elements of a circuit underlying object cognition in which stimulus attributes (colors, shapes, patterns) are encoded in working memory. In addition we will begin to investigate neural mechanisms of working memory in the auditory domain, which relates to the human comprehension of language and thought, a disorder of which could lead to the semantic anarchy of "loose associations". The second major objective is to begin the analysis of pre- and postsynaptic modulation of prefrontal circuits in monkeys performing delayed-response tasks. Following on our discovery that D1 antagonists impair working memory, we will explore in depth the role of dopamine receptor modulation in this function. In the light of the recent molecular biological identification of distinct dopamine receptor subtypes, a range of selective antagonists will be used in iontophoretic studies of functionally classified neurons. Interactions between dopamine receptor function and that of the excitatory and inhibitory amino acids, as well as cholinergic transmission will be examined in detail. Alpha adrenoreceptor actions will be investigated for comparison in function. To determine the dynamics (phasic versus tonic actions) of catecholamine function in either the induction or maintenance of delay- period activity, we intend to examine the relationship, in real-time, between transmitter release and neuronal activity during delayed-response tasks, using electrochemical detection. These studies are expected to provide insight into the neurobiological, neurochemical and neuroanatomical basis of working memory processes and thereby lead to an understanding of disordered thought processes in schizophrenia and other mental disorders.